Administrative Supplement 2: Improving Outcomes for Family Caregivers and Older Adults with Complex Conditions: The Adult Day Service Plus Program

We are requesting an administrative supplement to our current NIA parent grant “Improving Outcomes for Families and Older Adults: Adult Day Service Plus Program” (R01 AG049692; 2016-2021; PIs: L.N. Gitlin and J.E. Gaugler) to augment our study objectives. Specifically, we request funds to adapt ADS Plus for African American caregivers and expand our objective of translation and implementation to include a more heterogeneous caregiving population than we currently have been able to obtain. Our study aims for this supplement are to: Aim 1) Identify the cultural adaptations needed for recruiting ADS sites that serve African American communities. To accomplish this aim, we will work with two currently participating ADS Plus study sites that enroll African American caregivers. We will conduct key informant interviews with administrators and staff to help identify best practices and what matters to them most from which to develop a tailored value proposition to inform engagement strategies with other ADS sites serving African American communities. Aim 2) Develop and evaluate recruitment materials for African American caregivers. To accomplish this aim, we will conduct two focus groups in two sites with caregivers to determine what matters most to them in enrolling in a study, explore their reasons for participating or not in a study such as ADS Plus and identify incentives. Aim 3) Evaluate the effectiveness of an adapted recruitment strategy for ADS Plus for African American caregivers. To accomplish this Aim we will conduct telephone-based, data collection interviews (baseline, 3-, 6- and 12-month follow-ups) with 48-60 African American family caregivers. An exploratory aim will be to: 4) Identify if additional cultural adaptations are needed to the delivery (i.e. frequency of use, skill-building content) of ADS Plus to African American caregivers. To accomplish this aim, we will identify themes that emerge from the coaching calls with staff who are trained in the delivery of ADS Plus as part of our routine implementation activities of the parent grant. From these coaching calls, we seek to identify if sites delivering ADS Plus to African American family caregivers express unique experiences related to intervention delivery. Such refinements will not only support our parent R01 to achieve its research objectives, but also extend its scientific reach to address important challenges to including community-based organizations that primarily serve African Americans living with dementia, their family caregivers, and potentially other underserved populations that also feature prominently in the ADS Plus sample (i.e., Latino families).

Public health relevance
We request funds for an administrative supplement to our current NIA parent grant “Improving Outcomes for Families and Older Adults: Adult Day Service Plus Program” (R01 AG049692; 2016-2021; PIs: L.N. Gitlin and J.E. Gaugler). Specifically, we propose to adapt ADS Plus for African American caregivers and expand our ability to enroll sites and African American caregivers to enable testing of the intervention with a diversity sample. Funds will enable us to reach our objective of including a more heterogeneous caregiving population than we currently have been able to obtain in the parent grant.